Cell Models Core

Cell Models Core – Abstract
The DDRCC Cell Models Core proposes to provide DDRCC members with access to state-of-the-art tissue
culture models of digestive and liver disease. We will use genome engineering technologies including CRIPSR-
Cas9 to introduce genetic alterations into established cell lines and into induced pluripotent stem cells (iPSCs).
The iPSCs will be differentiated to form cells of the gastrointestinal tract and liver that will be used for study by
DDRCC members. The Core will also provide members with primary parenchymal and non-parenchymal livers
cells from both human and rodent livers as well as critical tools for the analyses of cells. In addition to providing
DDRCC members with cell lines that can be used for direct analyses, the Core will also provide members with
training and critical reagents that will allow them to establish many of the procedures in their own laboratories.
The Core will adopt a program of rigorous evaluation that will ensure that it performs optimally and continues to
provide DDRCC members access to new technologies as they are developed. Dr. Duncan, who will lead the
core, is an expert in stem cell biology and cell differentiation, and he has used genome engineering extensively
to generate cells to model liver disease. He will be supported by Dr. Don Rockey who has extensive experience
in the isolation of cells from both human and rodent livers.